New mechanisms in axon regeneration

PROJECT SUMMARY
Axon regeneration is a fundamental and conserved property of nervous systems. But axon
regeneration often fails to restore function after nerve injury. Thus, a key question in the field is
to discover what determines the capacity of injured neurons to rebuild functional circuits. This
proposal investigates new mechanisms that function in the injured neuron and that help
determine whether or not effective regeneration occurs. The long-term goal is to gain a
comprehensive understanding of the cellular functions that link neuronal injury to successful
functional regeneration. The specific goal of this project is to analyze the process of synapse
regeneration. The project uses a combination of in vivo approaches aimed at understanding
how synapse regeneration works, why it fails to restore normal function, and how it can be
improved. Completion of these Aims will describe fundamental cellular mechanisms that
mediate functional axon regeneration after nerve injury.

Public health relevance
PROJECT NARRATIVE The proposed research investigates novel mechanisms in axon regeneration, a critical process that can restore function after nerve injury. Failure of neurons to regenerate and rebuild circuits after injury results in permanent functional loss and is a significant burden on public health. The research proposed here is expected to result in fundamental knowledge that suggests ways to promote functional recovery after nerve injury.